Developing a Smartphone Application to Support the Functional Needs of Veterans in Medication Treatment for Opioid Use Disorder

The proposed Career Development Award (CDA2) would support Dr. Noah R. Wolkowicz, a Clinical
Psychology postdoctoral fellow with the VISN 1 New England Mental Illness Research, Education, and Clinical
Center (MIRECC), in his goal of becoming a Research Psychologist within the VA focused on developing
technology-based interventions to support the psychosocial functioning of Veterans with addictive disorders.
Opioid Use Disorder (OUD) is a chronic, relapsing condition that prompts a variety of functional problems
(e.g., social disengagement, unemployment). Despite the efficacy of Medication treatment for Opioid Use
Disorder (MOUD; buprenorphine, methadone), OUD’s impacts on optimal psychosocial functioning often
extends beyond what is pragmatically feasible for resource-strained MOUD clinics. Further, implementation of
treatments designed to improve psychosocial functioning, such as Acceptance and Commitment Therapy
(ACT), are themselves resource intensive, potentially limiting use and efficacy. Thus, to provide a minimally
burdensome alternative to support the psychosocial functioning of Veterans in MOUD, the proposed research
will develop a tailored mobile app-based treatment: ACT to RECOVER (Realizing Empowerment through
Commitment, Openness, and Valuing Experiences in Recovery). ACT to RECOVER will draw on the efficacy of
ACT, an existing, evidence-based, and functionally oriented psychosocial treatment, to provide support for the
pursuit of personally meaningful goals (e.g., reconnecting with family, job pursuit) alongside standard MOUD.
Research aims and app creation will occur across 3 parallel Phases consisting of content development (Phase
1), iterative usability testing and app refinement (Phase 2), and a Stage 1b pilot Randomized Controlled Trial
(RCT) to assess acceptability and feasibility of ACT to RECOVER and study procedures in preparation for a
larger efficacy trial if indicated (Phase 3). In Phase 1, ACT to RECOVER content will be developed via
consultation with ACT experts/project mentors, as well as qualitative input from VA MOUD Veterans and
clinical providers. In Phase 2, the delivery mode and content of the ACT to RECOVER app will be iteratively
assessed and refined across 3 small waves of Veteran participants. Finally, in Phase 3 we will examine the
feasibility and acceptability of ACT to RECOVER versus a smartphone-based, symptom monitoring control
condition through a Stage 1b pilot test. These aims will directly inform and support a subsequent RR&D Merit
proposal to conduct a full-scale RCT of the resulting intervention and will also provide invaluable experience
for the candidate’s intended long-term career path. The current proposal’s training aims are designed to
prepare Dr. Wolkowicz as a leader in technology-supported psychosocial intervention development within VA
by building skills in (a) iterative usability testing for technology-supported interventions, (b) ACT practice and
intervention research, (c) clinical trials methodology, (d) advanced statistical techniques, and (e) immersion
within VA addiction and technology leadership. Research and training aims will be met through mentor
collaboration and consultation with field experts, alongside formal didactic experiences (e.g., Yale courses in
clinical trials methodology). The current proposal will address a critical need to reduce harms to Veterans with
OUD, aligned with VHA priorities, and provide invaluable protected time for mentorship and training to the
applicant. Ultimately, the research and training outlined in the current proposal will position Dr. Wolkowicz to
become a leading researcher in technology-supported treatments for Veterans with addictive disorders.

Public health relevance
Opioid Use Disorder (OUD) is a chronic and complex problem that affects many parts of daily living (e.g., poor health, unemployment). Medication treatments for OUD (MOUD; e.g., buprenorphine, methadone) are essential for reducing relapse and overdose, but many Veterans require more support to improve their daily living. Unfortunately, MOUD clinics often have limited resources and are unable to provide additional behavioral therapy. One way to overcome these resource limitations is to deliver behavioral therapy using smartphone apps. This CDA2 proposal would develop a targeted app to help Veterans with problems of daily living, alongside their standard MOUD. It would also provide the applicant with necessary training to pursue a VA research career focused on creating technology-based treatments (e.g., smartphone apps) for Veterans with addictive disorders. Technology-based treatments represent a valuable way to deepen the support for Veterans with addictive disorders in a system already committed to patient-centered, evidence-based care.